Examining nicotine relapse in the habenulo-interpeduncular system

PROJECT SUMMARY
Chronic exposure to nicotine in tobacco products results in numerous health consequences (lung cancer,
emphysema, hypertension, etc.) and accounts for over 6 million deaths per year. Relapse rates are high among
those who attempt to quit smoking, and pharmacotherapies that seek to foster smoking cessation have limited
effectiveness. Thus, there is a significant unmet need for more effective strategies to treat nicotine dependence.
Nicotine exposure produces physical dependence, and the physical and/or emotional nicotine withdrawal
symptoms – as compared to the rewarding effects of nicotine – are often the most important contributors to
relapse. Importantly, nicotine cravings and the risk for relapse tend to peak 1 to 2 weeks after the beginning of
abstinence. Unfortunately, few research studies have probed the important question of how/why relapse
behavior develops. Indeed, a critical gap in knowledge exists regarding our understanding of how chronic
nicotine exposure encourages nicotine seeking during abstinence. In this project, we will use a rat nicotine self-
administration model to study the medial habenula (MHb) and interpeduncular nucleus (IPN), which together
comprise a crucial pathway involved in nicotine-related behaviors. Nicotinic acetylcholine receptors (nAChRs),
the pharmacological target of nicotine, are densely expressed in this pathway and are responsible for nicotine's
psychoactive and addictive properties. In this project, we intend to identify the relevant nAChRs and brain
circuits involved in nicotine seeking during abstinence. Three independent and complementary AIMs are
proposed, each of which probes a specific mechanistic aspect of relapse-like behavior. In AIM 1, we will use
biophysical techniques, 2-photon imaging, and fiber photometry to probe the relationship between MHb
neuronal activity and nicotine seeking during abstinence. AIM 2 will use electrophysiology, 2-photon imaging,
and a DREADD approach to examine the role of IPN neurons in nicotine seeking. Finally, AIM 3 will identify
specific IPN nAChRs involved in nicotine seeking and determine the importance of nicotinic cholinergic receptor
activity in producing nicotine craving and resultant nicotine seeking. Together, these AIMs will help us
understand how cessation of nicotine intake causes the brain to generate aversive physical and emotional
withdrawal responses that inevitably lead to relapse. Solving this problem could lead to new strategies or drugs
to foster smoking cessation.

Public health relevance
PROJECT NARRATIVE Addiction to tobacco products is exceedingly common in the United States, and nicotine withdrawal and subsequent relapse is a significant contributor to the addiction process. The goal of this project is to leverage our well-qualified research team, our innovative tools, and our incisive methods to identify mechanisms that support tobacco addiction. By identifying these mechanisms, our project will promote the development of new and more effective strategies to help people quit smoking.